Real-Time, Non-Invasive Thrombus Characterization using Ultrasound Responsive Nanodroplets

ABSTRACT
Thrombosis is a leading cause of morbidity and mortality worldwide, associated with several serious health
complications including pulmonary hypertension, cardiovascular disease, and death. As thrombi mature, their
structural and mechanical properties change, becoming mechanically less compliant due to fibrin crosslinking
and gradual collagen deposition. The evolving mechanical properties of thrombi over time necessitates a
dynamic and adaptable approach for timely diagnosis and treatment management. However, current diagnostic
methods are primarily for detection of thrombi and fail to provide critical information about thrombus age and
mechanical characteristics. This limitation highlights the importance of mechanistic understanding of histological
(e.g., composition) and mechanical (e.g., elastic modulus) changes that occur as thrombi age, which is critical
for refining treatment strategies tailored to thrombus development stage and optimizing patient outcomes. Due
to the dynamic nature of thrombi and limitations of existing diagnostic methods, there is a critical need to develop
a methodology for real-time quantification of evolving thrombus characteristics, such as age and elastic modulus.
This will help understand the clot aging mechanism better and guide appropriate treatment selection. Our long-
term goal is to develop an in situ micro-rheology technique that can non-invasively and spatiotemporally
characterize aging thrombi in real-time using ultrasound responsive nanodroplets. These nanodroplets are
designed to phase-transition into microbubbles when exposed to focused ultrasound above a threshold
amplitude, a process known as acoustic droplet vaporization (ADV). While ADV has been utilized in several
biomedical applications, such as drug delivery and super-resolution contrast imaging, its potential in micro-
rheology remains unexplored. Ultrasound responsive nanodroplets can be administered intravenously and
activated when they reach the thrombus site. These nanodroplets have several advantages, including their ability
to form bubbles during ultrasound exposure and then rapidly recondense once the ultrasound is turned off.
Additionally, their pharmacokinetic properties, such as longer circulation times due to their small size and liquid
core, further enhance their effectiveness. ADV bubbles are highly sensitive to medium properties, enabling
quantification of mechanical properties based on their acoustic emissions. The objective is to correlate the
acoustic emissions of ADV bubbles with the mechanical properties of aging thrombi. The central hypothesis is
that acoustic emissions of the ADV bubbles can be used to quantify thrombus age and elastic modulus. To test
this hypothesis, we will pursue three specific aims. 1) Quantify the impact of medium properties on the acoustic
emissions of ADV bubbles in thrombus-mimicking hydrogels. 2) Determine thrombus characteristics in an in vitro
venous flow model. 3) Demonstrate in situ characterization of thrombus in an inferior vena cava model. The
successful completion of the proposed research will be significant because it will establish a novel platform for
non-invasive, real-time, and super-resolution characterization of aging thrombi.

Public health relevance
PROJECT NARRATIVE Developing techniques to monitor thrombus characteristics dynamically over time can enable timely diagnosis and patient-specific treatment strategies. In this proposal we will develop an in situ micro-rheology method for real-time, non-invasive characterization of aging thrombi. This approach will use ultrasound responsive nanodroplets that phase-transition into microbubbles when exposed to focused ultrasound in a process known as acoustic droplet vaporization.